NAMPT regulation of fracture tissue metabolism during bone healing

This proposal will optimize NAD functions in the metabolism of fracture tissues for the enhancement of
bone fracture repair in an obesity/Type-2 diabetic condition, a condition that is common in the general
population and even more frequent among veterans. It is well established that Type-2 diabetics suffer from
impaired bone healing caused by an insufficient metabolic response to the requirements of tissue repair. In
this study, an obesity/Type-2 diabetes condition will be induced in mice and the redox potential of local
tissues improved through the augmentation of NAMPT functions in the fracture tissues. Selected agonists of
NAMPT will be screened for their effects in periosteal cells, therapeutic candidates locally applied to the
fracture tissues in obesity/Type-2 diabetic mice and fracture healing evaluated. The completion of the
proposed studies should facilitate the development of novel therapeutic interventions that improve tissue
responses to the metabolic requirements of wound repair.

Public health relevance
Tissue repair places many metabolic requirements on the wounded tissue for adequate healing and suffers from the detrimental effects of many pathological conditions. Obesity and diabetes are critical conditions that impair the metabolic regulation of many tissues. This proposal will optimize NAD functions in the metabolism of fracture tissues for the enhancement of bone fracture repair in an obesity/Type-2 diabetic condition. Obesity and the associated condition of Type-2 diabetes have become more frequent in the general population and are even more serious among aging veterans. It is well established that Type-2 diabetics generally suffer from impaired tissue and bone healing caused by an insufficient metabolic response to the requirements of tissue repair. Among the many documented effects of Type-2 diabetes on bone, the critical processes of osteogenesis and vascularity are reduced. Wound healing in challenging physiological conditions such as diabetes and obesity is therefore particularly problematic in bone repair and requires novel approaches that optimize tissue metabolism for healing. This study will develop novel local therapeutic approaches to improve the tissue redox potential and promote bone repair in an obesity/Type-2 diabetes condition. This intervention will increase NAD production and fracture tissue metabolism through the local application of NAMPT agonists and augment NAMPT functions in the NAD salvage pathway. To achieve these objectives, selected agonists of NAMPT functions will be screened for their action on periosteal cells and identified as therapeutic candidates for the enhancement of NAD biosynthesis. These NAMPT agonists will subsequently be applied locally to the fracture tissues of mice induced to an obesity/Type-2 diabetic through a high-fat diet and bone repair then evaluated. We have acquired exciting preliminary data demonstrating that local applications of an antagonist of NAMPT inhibits the functions of bone cells in vitro and impairs bone formation in vivo in the fractures of normal mice. It therefore stands to reason that the local application of an agonist of NAMPT functions would produce the opposite effect, enhancing NAD production and tissue metabolism, promoting bone formation in mice with physiologic conditions of reduced tissue metabolism and ultimately enhancing otherwise impaired bone fracture healing. We have chosen the obesity/Type-2 diabetic condition to test our hypothesis that augmenting NAMPT functions through the local application of an NAMPT agonist improves bone formation and fracture repair in an obesity/Type-2 diabetic condition, we hypothesize that NAD production is insufficient to maintain the tissue metabolism necessary for sufficient bone formation and fracture repair. Two specific aims are proposed to develop this approach. 1) Agonists of NAMPT function will be screened in those bone cells established as mediators of endochondral bone formation, specifically periosteal cells. The effects of these NAMPT agonists on bone cell proliferation, motility and redox potential will be characterized. 2) Candidate NAMPT agonists that are especially potent or multifunctional in the enhancement of these functions in periosteal cells will subsequently be injected directly to the tibial fractures of mice that have been induced to the obesity/Type-2 diabetes condition through a high-fat diet. The effects of these agonists on bone repair in this condition will be characterized by various radiologic and histologic approaches for their promotion of healing. The results will help to develop local therapeutic interventions that improve impaired bone fracture repair. The completion of the proposed studies should facilitate the development of novel therapeutic interventions that improve tissue responses to the metabolic requirements of wound repair and promote the healing of skeletal and non-skeletal tissues in challenging conditions such as age, obesity and diabetes.